Determining the impact of post-translational modification on Serine Arginine Splicing Factor 7 during macrophage activation

Project Summary
There is a fundamental gap in our understanding of how RNA processing factors, specifically splicing proteins,
respond to environmental changes and extracellular signals. The overall objective of this proposal is to define
how the splicing factor SRSF7 is post-translationally modified and functionally altered in innate immune cells
following activation by pathogen sensing. Misregulation of splicing accounts for a multitude of human diseases
due to hereditary and somatic mutations in both cis and trans factors. Trans-acting splicing factors include aux-
iliary splicing factors such as the Serine Arginine Splicing Factor (SRSF) family, and a recent phosphoproteomics
experiment demonstrated that five SRSF proteins are differentially phosphorylated in primary macrophages in-
fected with an intracellular bacterial pathogen. Upon stimulation of a macrophage cell line with lipopolysaccharide
(LPS), one differentially phosphorylated SRSF protein, SRSF7, moves from the chromatin fraction to the nucle-
oplasm and this movement is associated with an apparent gain in phosphorylation. This finding suggests that
pathogen sensing may alter the ability of SRSF7 to interact with protein binding partners and/or RNA on chro-
matin. Follow-up mass spec immunoprecipitation (MS-IP) of FLAG-SRSF7 in resting macrophages identified
novel interactions between SRSF7 and SNRP70, a component of the U1 SNRP, and HDAC6 an important his-
tone deacetylase. Additional preliminary data show that shRNA-mediated knockdown of SRSF7 represses levels
of interferon stimulated genes (ISGs) in macrophages, suggesting this factor plays an important role in regulating
innate immune gene expression. The central hypothesis of this proposal predicts that differential phosphory-
lation of SRSF7 impacts its ability to bind proteins and pre-mRNA, which changes how the splicing code
is read during macrophage activation. The two main goals of this project are to determine the contribution of
phosphorylation of SRSF7 to protein-protein interactions and splicing during macrophage activation and to iden-
tify the kinases involved in SRSF7 modification downstream of macrophage activation. To these ends, Aim1
uses immunoprecipitation to elucidate protein-protein interactions as well as RNA immunoprecipitation and RNA
affinity assays to link SRSF7 phosphorylation status with protein/transcript binding and gene expression out-
comes. Aim 2 employs biochemical inhibitors as well as genetic manipulation to determine the contribution of
specific serine-threonine kinases in phosphorylation of SRSF7 during macrophage activation. These experi-
ments will provide valuable insight into the activity and regulation of SRSF7 phosphorylation during macrophage
activation. Additionally, this project will further our understanding of the mechanisms driving cellular adaptation
to dynamic microenvironments. This work has high potential to shift paradigms regarding how a variety of envi-
ronmental stresses (e.g. starvation, UV stress, heat shock, osmotic stress, carcinogenesis) functionalize RNA
processing machinery and provides potential advancements for possible therapeutic interventions that correct
disruption of cellular homeostasis by modulating pre-mRNA splicing.

Public health relevance
Project Narrative Regulation of RNA processing is critical to establish a proper cellular response to dynamic cellular microenvironments. The goals of this project are to understand how the RNA-binding protein SRSF7 regulates splicing in response to macrophage activation following pathogen sensing and to implicate phosphorylation of SRSF7 in this process. Elucidating how post-translational modifications impact splicing factor function will allow us to better develop therapeutics designed to correct mis-splicing events associated with disease.